ADMINISTRATIVE

The Administrative Core will be the central office for the administration of the Program Project. It will be coordinated through the Department of Pathology. The Principal Investigator, Dr. Darrel Stafford and the Administrator, Cynthia Taylor will meet regularly to go over items of interest pertaining to fiscal matters of all projects. The internal advisors will be contacted on a regular basis to keep members up to date on the research accomplishments. The external advisors will be invited to visit as needed to meet with the principal investigators of each sub project for comments and critique of research progress. These advisors will be charged with altering the scientific direction of each sub project should the need arise. The Administrative Core will insure smooth integration between the individual projects and will oversee weekly meetings of the investigators in room 442 of Wilson Hall. The Administrative Core will also coordinate the visits of the External Advisory committee and will be responsible for organizing the scientific program to be presented to the Advisory Committees. The Administrative Core will also organize all meetings of the Principal Investigators of the sub projects and will be responsible for the preparation of manuscripts, abstracts, human and animal rights protocols, monthly financial reports, and annual progress reports relating to the program project. Travel to scientific meetings by the members of the program project will be organized by the Administrative Core although travel requests will be in each individual sub project. The accounting mechanism for this program project will be carried through the Administrative Core as overseen by Ms. Cynthia Taylor, Administrator and with the direction of Dr. Darrel Stafford. All expenditures will be monitored by Ms. Taylor. The Administrative Core will also be responsible for communications with the NHLBI of the NIH, and the Office of Sponsored Research of the University of NC at Chapel Hill.